Whole Blood Point of Care Metabolic Measurement

Project Summary
This SBIR Phase II project will translate Phase I technical innovations in sensor materials and a prototype
device into a fully functional point of care technology for whole blood biomarker monitoring. It will culminate in a
complete draft of a 510(k) clearance application to the U.S. Food & Drug Administration (FDA). Currently, no
commercial FDA cleared point of care device is available for direct measurement of this biomarker in whole
blood. All large clinical instruments require separation of plasma from whole blood via centrifugation prior to
measurement. Further, current clinically used measurements, which rely on plasma separated from whole
blood, suffer from inaccurate results from pre-analytical variability in sample handling.
Phase I completed technical innovations supported by the National Science Foundation yielded 1) increased
sensor specificity, by eliminating signals from interferents, 2) increased sensor sensitivity through sensing
material improvements, and 3) direct point of care measurement from whole blood, instead of plasma
separated ex-situ from the measurement device which eliminated pre-analytical variability in sample handling.
This novel point of care whole blood measurement device will be used to improve at-home management of the
~10,000 people living with these rare metabolic disorders and as a newborn screening to improve identification
of the ~1/3500 newborns with rare metabolic disorders out of the 3.9 million annual births in the United States.
Ultimately, manufacturing of consumable, single use sensors and sensor readers will create new jobs in the
United States.
In this Direct Phase II project, Sequitur Health Corp. will partner with Arizona State University and Mayo Clinic
to innovate a process for mass production of the laboratory-scale sensors developed from the Phase I
project and subsequently analytically and clinically validate the mass-produced sensors and reader
technology for FDA 510(k) clearance.

Public health relevance
Project Narrative Relevance to Public Health: The objective of this Phase II project is to innovate a manufacturing process to mass produce sensors for a new point of care blood measurement device and validate their accuracy for Food and Drug Administration clearance. Long term, implementation of this device for daily home monitoring of this blood marker and screening of newborns with this marker will improve management and identification of these disorders. Rapid measurement at the point of care of this blood marker will improve quality of life by enabling timely use of known effective treatments to reduce this blood marker.